Data Management and Analysis Core

PROJECT SUMMARY – Data Management and Analysis Core (DMAC)
The Data Management and Analysis Core (DMAC) provides state-of-the-art data management support and
cutting-edge statistical and geospatial analysis assistance for the Research Projects and Cores of UNM METALS
Phase 2 Center. The DMAC will be co-directed by Li Luo and Yan Lin with complementary and collaborative
experience in biostatistical and geospatial analyses to manage all aspects of the Core. DMAC members include
eight quantitative scientists with complementary expertise in data management and statistical and geospatial
analysis for a variety of scientific domains. DMAC members have backgrounds and expertise in modern data
management, biostatistical methods, geospatial analysis, Bayesian methods, causal inference, as well as
analyses of data from basic science, translational research, population studies, and environmental health
disparities research. The team members have collaborated for over five years on multiple environmental health
projects, and have streamlined the workflow from data collection, quality control, statistical and geospatial
analysis support, and methodology developments to enhance the analysis of complex metal mixtures. The
DMAC will implement and provide data management support that is compliant with four foundational principles:
Findability, Accessibility, Interoperability, and Reusability (FAIR). DMAC will develop and utilize a centralized
data repository that connects different types of data storage systems and FAIR platforms to faciliate data sharing
and integration. The data and analytical support provided by the Core will contribute to many aspects of the
research process including, but not limited to, efficient study design, appropriate monitoring of data safety,
enhanced data management capacity, state-of-the-art statistical and geospatial analyses, assistance in the
development of study protocols and contract proposals, as well as sample size and power calculations. In
addition, DMAC members will assist Research Projects and Cores in preparing summary analytical reports and
manuscripts. Furthermore, DMAC will develop integrated statistical and geospatial modeling to refine the risk
classification based on study participants’ comprehensive environmental exposure profile, and to understand the
mechanisms of the adverse effects of toxic exposures on the health outcomes mediated through intermediate
biomarkers. Core faculty will also provide educational opportunities to Center investigators and trainees through
lectures, workshops, and hands-on training. The collaborative efforts of Core members will contribute not only
to effectively pursuing hypothesis-driven research questions but also to developing novel research questions
and methods for complex analyses of large datasets. Core members will work closely with METALS Research
Projects and Cores to develop and integrate new methodologies into various research projects. The DMAC is
well-positioned to promote multidisciplinary research collaboration and develop analytical strategies to contribute
to the successful completion and integration of Research Projects and Cores within the METALS Center.

Public health relevance
Project Narrative – Data Management and Analysis Core (DMAC) The Data Management and Analysis Core (DMAC) has direct public health relevance as it will provide analysis support for the UNM METALS research projects, and perform comprehensive assessments of environmental exposure profiles to search for disease risk factors. The DMAC will also develop integrative modeling of the environmental and biological research data to detect unique exposure profiles for risk classification and disease prevention. It will also provide valid data and scientific conclusions that can be translated to inform intervention strategies with the ultimate goal to improve community health.